Imaging neuroglial mechanisms of neuropathic pain-opioid interaction in HIV

PROJECT SUMMARY/ABSTRACT
Since the World Health Organization declared COVID-19 a pandemic in March 2020, increasing evidence
shows that COVID-19 affects multiple organs, including the central nervous system (CNS). Effects of COVID-
19 on the CNS have been well documented in the hospitalized setting by magnetic resonance imaging (MRI)
and spectroscopy (MRS), blood and cerebrospinal fluid biomarkers and autopsy. Neurological problems
associated with COVID-19 can persist long past recovery from the initial stages of COVID-19, including fatigue,
cognitive blunting, and body pain which are among the top 10 symptoms reported by COVID-19 survivors.
According to the Center for Disease Control, people with HIV (PWH) may be at higher risk for severe outcomes
from COVID-19, and the long-term neurological sequelae in this population is unknown and may represent a
clinical phenotype at risk for future health threats (i.e., development of cognitive disorders). Data informing the
underlying biology of prolonged symptoms in COVID-19 is limited, and how COVID-19 and HIV may interact to
affect neurological function is urgently needed. Based on the clinical presentation of COVID-19, complications
ranging from mild-to-severe, and known triggers of cerebral pathology, neuroinflammation (Aim 1) and loss of
neuronal integrity (Aim 2) are expected to be important components of post-acute sequalae of COVID (PASC).
To evaluate neuro-glial dysregulation in people with PASC, we will use advanced brain imaging technologies,
neuropsychological testing, fatigue measurements and quantitative sensory testing (QST). Specifically,
integrated [11C]PBR28 Positron Emission Tomography / Magnetic Resonance (PET/MR) and 3-Tesla proton
magnetic resonance spectroscopy (1H MRS) will be used to evaluate brain levels of glial markers (18kDa
translocator protein, TSPO, and myo-inositol, mI), and neuronal / structural integrity markers (N-
acetylaspartate, NAA). QST techniques will assess pain threshold, suprathreshold sensitivity and temporal
summation, while cognitive function will be assessed using detailed neuropsychological battery designed for
COVID-19 patients to assess concentration and attention. People with persistent neurological symptoms after
COVID-19 will be enrolled for this supplemental award. The parent R01 will provide two comparator control
populations that include people with and without HIV who were not previously infected with COVID-19. Group
differences in magnetic resonance markers of neuroinflammation and neuronal integrity and their associations
with neurological symptoms including cognitive function and pain will be investigated. The mechanistic insights
provided by this supplemental study in HIV-COVID-19 interaction will inform the care and neurological
management of people with COVID-19, including PWH, and who are expected to suffer long-term
consequences of the pandemic for years to come.

Public health relevance
NARRATIVE The mechanisms underlying long-term neurological symptoms in people who have recovered from the acute phase of COVID-19 illness are currently unknown. The goal of this project is to use PET/MR imaging and high- field MRI and MR spectroscopy to image brain glial activation and neuronal integrity in people with and without HIV who have post-acute sequelae of COVID-19. Defining the biological basis of persistent neurological symptoms will be critical for developing therapies specifically targeting the underlying pathologic mechanisms associated with the long-term consequences of COVID-19 and to provide appropriate care to these individuals.